Novel ocular imaging and molecular analysis of anterior eye segment for glaucoma

Project Summary
Glaucoma is the leading cause of irreversible blindness worldwide and is a heterogeneous group of ocular
diseases characterized by optic nerve damage and impaired vision. The majority of glaucoma patients are elderly
due to the age-related, optic nerve disease, whereas there are early-onset forms of glaucoma: primary congenital
glaucoma and developmental glaucoma. The resistance to drainage of aqueous humor from the anterior
segment of the eye into the systemic circulation leads to the elevation of intraocular pressure (IOP), and elevated
IOP is the primary and only modifiable risk factor for glaucoma. Despite the current treatment options aimed at
lowering IOP, there are urgent needs to develop new, more effective therapeutic approaches. Aqueous humor
drainage as the conventional outflow pathway is mediated through the trabecular meshwork (TM), which is
derived from the neural crest (NC) lineage, into a specialized, lymphatic-like vessel known as Schlemm's canal
(SC). Recent evidence indicates that SC has specialized and unique vascular endothelial cells (ECs) and that
the signaling pathways such as Angiopoietin/Tie2 are essential for the formation and maintenance of SC
vasculature. The long-term goal of our group is to elucidate the fundamental mechanisms that regulate SC
maintenance/function and to understand how disruption of these mechanisms leads to impaired outflow causing
increased IOP in pathological settings. To image the full-circle SC and evaluate TM stiffness in mice, our group
has recently developed a circular-scanning visible-light OCT (vis-OCT) system. FOXC2 is a member of the FOX
(Forkhead box) transcription factor family and has critical roles in vascular development and disease. Inactivating
mutations in human FOXC2 are dominantly associated with lymphedema, which is characterized by obstructed
lymph drainage in the limbs, and recent evidence has shown that FOXC2 variants possess a role as putative
modifiers for the development of primary congenital glaucoma. However, its role in TM and SC cells has yet to
be fully investigated. The results from our preliminary experiments via vis-OCT imaging, immunohistochemistry,
and single-cell RNA sequencing indicate that the NC-Foxc2-/- mutation is associated with defective TM formation,
abnormal SC morphology, or the absence of the SC, a reduction in expression of PROX1, VEGFR3, and TEK
in SC ECs, and elevated IOP, and that the EC-Foxc2-/- mutation results in impaired SC formation. Our central
hypothesis is that novel diagnostic vis-OCT imaging techniques elucidate the significance of Foxc2 function in
both NC-derived TM cells and SC ECs in SC formation/maintenance and TM stiffness. To test this hypothesis,
we have two Specific Aims. First, we will develop a new balanced-detection vis-OCT to determine the anatomical
influence of the Foxc2 regulatory network in SC formation/maintenance. Second, we will develop new
methodologies to evaluate TM stiffness based on vis-OCT phase imaging after high-speed temporal speckle
reduction to define the functional influence of the Foxc2 regulatory network in TM stiffness and ECM
compositions.

Public health relevance
Project Narrative The proposed research is relevant to public health because glaucoma is the leading causes of irreversible blindness worldwide, but its causes and underlying mechanisms are poorly understood. The results of the proposed studies with new cutting edge imaging technologies will significantly contribute to a better understanding of the mechanisms underlying the formation and function of the trabecular meshwork and Schlemm's canal. Thus, the proposal is relevant to the NEI's mission and is likely to lead to the identification of new targets and therapeutic strategies for improving the drainage of aqueous humor from the anterior segment of the eye in affected patients.